Core 2: Biorepository, Biomarker Analysis and GI Organoids

CORE 2 ABSTRACT
In this renewal, all three projects share an integrated, synergistic focus on GI GVHD. Core 2 has
developed new services related to GI GVHD in both clinical and experimental BMT in order to meet this
focus of all three projects. The core continues to maintain and curate the MAGIC biorepository (objective
1). During this cycle we collected and processed more than 30,000 research samples from 3000 patients.
Samples are aliquoted into barcoded tubes that are linked to the patient, date and sample type. The core
also continues to provide central analysis for both human and mouse biomarkers (objective 3). We have
developed rigorous quality control processes for real time screening of patient samples for clinical trial
eligibility and reporting of results to all participating sites within 24 hours.
The first new service provided by this core (objective 2) is the use of computer programming to enhance
the flexibility of the MAGIC biorepository and database. This programming reduces data errors and
facilitates rapid creation of contemporaneous controls for single arm clinical trials. The second new
service (objective 4) establishes and analyzes gastrointestinal organoid cultures. These cultures permit
the analysis and quantification of intestinal stem cells in models of GVHD damage in vitro that permit
evaluation of key survival and apoptotic pathways.
The objectives therefore are:
1. To maintain and curate the MAGIC biorepository.
2. To use computer programming to enhance the flexibility of the MAGIC biorepository and facilitate its
linkage to the clinical database.
3. To provide central analyses of both human and mouse biomarkers.
4. To provide a central process for the establishment and analysis of GI organoids.

Public health relevance
CORE 2 NARRATIVE Allogeneic hematopoietic stem cell transplantation is a potentially curative therapy for many malignant diseases whose applicability has been impeded by the development of its most serious complication, GI GVHD. Strategies that strengthen the target cells in the GI tract will allow for better harnessing of this effective therapeutic modality. Core 2 provides support for organoid models, biomarker analysis and computer programming, and is used by all three projects.